Career Development Program

The DF/HCC GI SPORE Career Development Program (CDP) is designed to provide the incentive and structure necessary to attract junior investigators in basic, translational and clinical research into GI cancer. The overall goal of the CDP is to nurture the success of talented new researchers in GI cancer. By providing research support and exposure to the GI SPORE investigators, we hope to promote the independent research careers of junior faculty. Moreover, the SPORE CDP strives to attract minority and female investigators to the field of GI cancer. The investigators assembled in the DF/HCC GI SPORE have a substantial record in mentorship of junior faculty working in GI cancer research. The GI SPORE CDP has established a formal process for the identification, selection, and mentoring of individuals pursuing careers in the study of basic, clinical, and population science-based aspects of GI cancer. The CDP Governance and Review Committee, led by outstanding senior mentors across BWH, MGH, DFCI, and BIDMC, direct a program that ensures optimal selection, support, and oversight of the GI SPORE CDP. Over the past funding cycle, the CDP has selected, funded, and mentored 15 talented young investigators in GI cancer who have made exceptional career development as well as substantial contributions to the field of GI cancer. The Specific Aims of the Career Development Program are: 1. Establish a system to identify promising young investigators seeking to become independent investigators in GI cancer research. 2. Provide funding and resources and monitor awardee progress. 3. Promote a mentoring environment in the SPORE that will assist in the career development of CDP awardees as well as other junior faculty. 4. Train and develop the next generation of leaders in GI cancer translational investigation.

Public health relevance
Career development of young faculty is vital to the continued progress in reducing the burden of GI cancer. The DF/HCC GI SPORE Career Development Program (CDP) is designed to provide the incentive and structure necessary to attract junior investigators in basic, translational and clinical research to focus on key issues in GI cancer.